CTBI: Traumatic brain injury-induced inflammation effects on cognitive evaluations and response inhibition: Mechanisms of increased risk for suicidality

In 2019 Veteran suicides were double that of civilians. Suicide risk detection is a VA priority, but
suicide prevention requires disclosure of suicidal thoughts and behaviors, and less than half of
suicide decedents make such disclosures before death. This project will collect data on prior
Veteran suicide disclosures, such as their proximity to suicide attempts, others’ reactions to such
disclosures, and the Veteran’s self-reported likelihood of future suicide disclosure. It will also
study potential influences on suicide disclosure among Veterans, such as trust of partners and
providers, mental health stigma, suicide-related coping, and attitudes and beliefs about services
with mental health providers. It will further examine racial/ethnic differences in the influence of
these factors and study minority-specific potential barriers and facilitators of suicide disclosure,
such as cultural values/attitudes regarding suicide and racial/ethnic discrimination.

Public health relevance
In 2019 Veteran suicides were double that of civilians. Suicide risk detection is a VA priority, but suicide prevention requires disclosure of suicidal thoughts and behaviors, and less than half of suicide decedents make such disclosures before death. Prior research suggests interpersonal factors, such as trust of others by individuals at high risk for suicide, are fundamental to suicide disclosure, and that this trust is often established for potential future suicide disclosures by reactions of suicide disclosure recipients to prior suicide disclosures. Further study of barriers and facilitators of suicide disclosure is needed to expand upon this knowledge. The current study seeks to help address this gap. OEF/OIF/OND Veterans, 18-65 years of age, will be recruited from a larger study of suicide and traumatic brain injury. They will be interviewed regarding prior suicide disclosure experiences. Factors describing prior suicide disclosure experiences will be discussed such as the proximity in time of specific suicide disclosures to prior suicide attempts, the type of relationship the Veteran has/had with the disclosure recipient (e.g., parent, partner, provider, pastor, pal, etc.), reasons for disclosing to a given recipient, the reaction of the recipient, rating the helpfulness versus hurtfulness of the experience, the method of disclosure used (e.g., in person, phone call, text message, email, online posting, etc.), the relative clarity of the disclosure, and how likely the Veteran would be to disclose again in the future as needed. Other potential influences on suicide disclosure among Veterans that will be examined via self-report inventories include trust of partners and providers, mental health stigma, suicide-related coping, attitudes about services with mental health providers, and beliefs about disclosing emotional difficulty to partners and providers. Additionally, racial/ethnic differences in the influence of these factors, and minority-specific potential barriers and facilitators of suicide disclosure will be studied. These will include acculturative stress, minority stress, emotional/somatic expressions of suicidal symptoms, cultural sanctions against suicide, and perceived racial/ethnic discrimination both broadly and in health care settings. The overall purpose of this study is to provide pilot data to facilitate further research regarding barriers and facilitators of suicide disclosure among Veterans, for the ultimate goal of promoting suicide disclosure among Veterans. Such research has the potential to inform VA suicide risk detection initiatives such as VA RISK ID and to improve VA suicide risk detection and prevention efforts broadly throughout the VA system. It also has the potential to inform suicide risk detection and prevention efforts more broadly throughout society.